Adipose Tissue Metabolic Stress Responses

Project Summary
Human obesity represents a serious world-wide health problem. One consequence of obesity is the
development of metabolic syndrome, characterized by insulin resistance and hyperglycemia, that can lead to b
cell dysfunction and type 2 diabetes. It is therefore important that we gain an understanding of the physiology
and pathophysiology of the development of obesity because this knowledge represents a basis for the design
of potential therapeutic interventions.
The cJun NH2-terminal kinase (JNK) signaling pathway functions during stress responses, including metabolic
stress caused by feeding a high fat diet (HFD). Importantly, loss-of-function studies using mice demonstrate
that deficiency of JNK1 plus JNK2 in adipocytes prevents adipose tissue inflammation and the development of
systemic insulin resistance. However, the mechanisms that mediate the actions of JNK signaling in adipocytes
are unclear.
We will focus our studies on two questions:
a) What is the physiologically relevant form of JNK that drives adipose tissue inflammation and insulin
resistance? Adipocytes express two genes that encode JNK (Mapk8 & Mapk9 encode JNK1 & JNK2,
respectively) and transcripts of both genes are alternatively spliced by mutually exclusive inclusion of exons 7a
& 7b. These alternative exons encode a segment of the substrate binding site. The JNK17a & JNK27a exhibit
similar substrate specificities that differ from the similar substrate preferences of JNK17b & JNK27b. We will
determine which of these JNK spliceoforms mediates effects of JNK on adipose tissue inflammation and
systemic insulin resistance.
b) What mechanism mediates the actions of adipocyte JNK? It has been proposed that the effects of JNK on
inflammation may be mediated by increased adipocyte IL6 expression and that the effects of JNK on systemic
insulin resistance may be mediated by decreased FGF21 expression. A rigorous test of the sufficiency of
these JNK-mediated actions on adipokine expression is required to confirm the actions of these JNK-
responsive adipokines and to identify whether there are additional targets of JNK signaling.
The overall goal of this research program is to identify molecular mechanisms that account for JNK function in
adipocytes. Achievement of this goal will increase understanding of the molecular response to obesity. We
anticipate that the successful completion of this research program will lead to the identification of new
mechanisms that contribute to the obesity response. This knowledge may represent a basis for the design of
novel therapeutic strategies for the treatment of metabolic syndrome and type 2 diabetes.

Public health relevance
Project Narrative The goal of this research program is to understand metabolic stress responses of adipose tissue. The focus of our analysis is on the stress responsive cJun NH2-terminal kinase (JNK) signaling pathway. We propose to combine physiological analysis together with an investigation of JNK isoforms to define molecular mechanisms that mediate adipose tissue stress responses. The knowledge obtained may represent a basis for the design of novel therapeutic strategies for the treatment of metabolic syndrome and type 2 diabetes.